Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The Administrative Core of the Mid-Atlantic Center for Cardiometabolic Health Equity (MACCHE) will be
responsible for the overall administration of the grant, including guiding and coordinating shared data and
intervention resources, Community Engagement Core and Investigator Development Core activities and
supporting the three research studies. The overarching goal of MACCHE is to test the effectiveness of
comprehensive, integrated, and multi-level evidence-based strategies for improving cardiometabolic health
outcomes among socially disadvantaged populations, using community-based participatory research and
patient-centered outcomes research principles, and translate them into clinical and public health practice. The
Administrative Core, constituted of experts in Clinical Medicine, Nursing, Epidemiology, Biostatistics,
Behavioral Science, Health Services Research, Implementation Science, and Community-Based Participatory
Research, will be responsible for executing that overarching goal and assuring that the “whole [Center] is more
than the sum of its parts”. The MACCHE Administrative Core will build upon the strong existing administrative
structure in the Johns Hopkins Center for Health Equity, which has used a comprehensive approach to health
equity that includes research and translation, education and training, community engagement, and local to
global learning since 2010.